Quantifying the Brain Metabolism Underlying Task-Based BOLD Imaging

Project Summary/Abstract
Recent evidence suggests that metabolic dysfunction is a crucial transdiagnostic risk factor for mental illness.
Functional MRI (fMRI) measures hemodynamic changes related to metabolic shifts in the brain and could
bridge a critical gap between biomarkers for mental illness and human experience and behavior; however,
metabolic processes underlying the hemodynamic response have remained poorly understood. Before we can
understand brain metabolic dysfunction in mental illness, we first need to understand brain metabolism during
healthy cognitive function. A particular point of controversy is that the BOLD response to sensory signals and
cognitive activity coincides with a substantial increase in glucose consumption, decoupled from increases in O2
metabolism. This process is called aerobic glycolysis. and its function remains disputed. We have developed a
hypothesis from converging lines of neurophysiological evidence that clarifies how aerobic glycolysis serves an
adaptive function in neuronal communication. The proposed research will contribute to basic science by
advancing the methods and theory needed to measure and interpret task-based brain metabolic dynamics. We
combine technical innovations in functional PET imaging (fPET) and dual-calibrated fMRI, to simultaneously
measure absolute rates and task-based relative changes in regional glucose and O2 metabolism. Aim 1
evaluates the reliability of hybrid PET/fMRI method, within and across scan sessions, and against prior PET-
derived estimates. Aim 2 tests a novel hypothesis about the role aerobic glycolysis plays in information
transmission. We hypothesize that aerobic glycolysis supplements energy for communicating unpredictable
sensory signals, i.e., prediction error. To test this, we will use a simple behavioral task, manipulating the
predictability of auditory and visual stimuli, crossed with an attention manipulation between sensory streams.
Aim 1 represents a critical advance in our ability to measure brain metabolic dynamics, as prior research has
been limited to performing independent PET sessions. Aim 2 tests a key prediction in a broader theoretical
framework, which has the potential to significantly reframe interpretations of existing fMRI research,
recontextualizing the hemodynamic response and “brain activation” in explicit informational and metabolic
terms.

Public health relevance
Project Narrative Recent evidence suggests that metabolic dysfunction is a crucial transdiagnostic risk factor for mental illness. Our proposed research advances the basic science necessary to measure and interpret individual dynamics in brain metabolism by (1) evaluating the reliability of a novel hybrid PET/fMRI neuroimaging approach, capable of simultaneously estimating absolute glucose and O2 metabolism and task-based relative changes, and (2) testing a novel hypothesis about the relationship between brain glucose metabolism and task-based “neural activity.”